OBESITY, CONDITIONING, AGE AND SERTRALINE EFFECTS ON METABOLISM

This study examines the relationship of body composition and physical fitness to insulin sensitivity, adipose tissue metabolism and sympathetic nervous system activity and the effects of weight loss and sertraline, a serotonin reuptake blocker, on these relationships.